Advancing Multi-Color EM via Direct Detector-enabled 4D-STEM

PROJECT SUMMARY
This focused technology development project will advance into first practice a transformative new imaging
technology for multicolor electron microscopy (ColorEM), enabling new capabilities for high resolution and 3
dimensional (3D) localization and differentiation of different molecular complexes in cells and tissues. With this
technology, we will substantively improve upon presently practiced, multiple labeling strategies involving
antibody labelling approaches detected using colloidal gold, quantum dots, etc.. We will further provide a more
accessible, higher throughput, and dose efficient alternative to spectroscopic methods, like energy dispersive
x-ray (EDX) and electron energy loss spectroscopy (EELS) / energy filtered transmission electron
microscopy (EFTEM). At the heart of this effort, we will exploit the performance characteristics of a next-
generation, ultra-high speed direct detection device (DDD), now being optimized and extended (by us with an
industry partner) for use with scanning transmission electron microscopy (STEM), a broadly deployed
capability on modern EM columns. The optimized application of this new pixelated STEM detector
technology, in combination with an extended palette of elemental probes and advanced software analysis,
will allow for unprecedented new capabilities for performing atomic number (Z) contrast imaging – a
process we call ColorSTEM. To bring this new integrated methodology into first practice, we will build on
recent feasibility studies and surmount remaining technical hurdles to 1) make multi-labelled EM specimens
with optimized elemental probe combinations; 2) troubleshoot the first use of a potentially transformative new
sensor technology and work out the methodology for employing it for Z contrast imaging; and 3) devise the
associated analytical/computational methodology for processing the very large resultant data sets to enable
unambiguous differentiation of molecular complexes selectively marked with elemental probes.

Public health relevance
PROJECT NARRATIVE This project aims to develop and facilitate the use of a new imaging technology for multicolor electron microscopy (ColorEM) by combining the use of new elemental probes, advanced sensor technologies, computational analysis, and scanning transmission electron microscopy (STEM). The proposed outcome of this focused effort is to deliver a functional solution for 3 dimensional (3D) localization and differentiation of different molecular complexes in cells and tissues that surpasses the current state-of-the art in terms of resolution, throughput, and broad accessibility.